Treatment of Rabbit Rotator Cuff Fatty Infiltration and Atrophy with Electric Stimulation and a PDGFRa inhibitor

Background: The PI proposes to test the hypothesis that inhibition of platelet-derived growth factor
receptor alpha (PDGFRa) and direct, submaximal electric stimulation (ES) synergistically prevents fatty
infiltration (FI) and muscle atrophy, improving function after rotator cuff tear. A large irreparable rotator
cuff tear with muscle FI is one of the most common diagnoses seen in his VA practice. According to the
Veterans Administration Surgical Quality Improvement Program, over 10,000 Veterans with rotator cuff
injuries underwent rotator cuff repairs over a six-year span. Surgical repair of a torn rotator cuff is
generally successful, though with a re-tear rate of 25 percent. We propose a novel method of FI
prevention and will study how this affects muscle function.
Fatty infiltration and atrophy leads to poor outcomes from tendon re-tear and decreased muscle
function. Objectives: The overall purpose of this proposal is to determine whether the treatment of
FI and atrophy improves outcomes in a rabbit animal model such as: animal gait, muscle function, and
rotator cuff healing.
 Aim 1: Determine if PDGFR inhibition and direct muscle ES at the time of rotator cuff tear can
improve muscle function by preventing FI and atrophy in an established rabbit rotator cuff
tear model.
 Aim 2: Determine if PDGFR inhibition and direct muscle ES can arrest/impede FI and
improve function using a delayed repair model in which FI and atrophy have been
established.
Research Design and Methodology: This study will utilize an established and reproducible rabbit in
vivo model of chronic rotator cuff tear and muscle fatty infiltration in Aims 1 and 2. Study outcome
measures for both aims include: in vivo contractile muscle function testing, rabbit gait analysis,
quantitative-based micro-CT imaging of muscle fatty infiltration, tissue analysis for fibro-adipogenic
cells and fat/fibrosis specific histology. Specific Aim 2 will utilize these same outcomes, as well as
tendon functional testing to determine viscoelastic properties.
Clinical Relationships: Rotator cuff tear with irreversible FI is common in the Veteran population and
precludes a successful repair and outcome. The ultimate goal is finding novel interventions that can
improve function for Veterans undergoing rotator cuff repair.
Impact/Significance: The proposed Merit Award will lay the groundwork for future clinical trials within
the next ten years by testing two Federal Drug Agency approved treatments for their synergistic effects
on the treatment of atrophic rotator cuff tears. This translational pre-clinical approach has the potential
to: reduce pain and improve Veteran's ability to function independently and return to physical work.
Furthermore, it will provide valuable research support for the applicant as he pursues a career as an
orthopaedic surgeon-scientist at the VA Maryland Health Care System. [The PI has a team of three
co-investigators experienced in rotator cuff imaging, rotator cuff muscle physiology and adipocyte
formation.]

Public health relevance
Rotator cuff injuries are a cause of disability and reduce Veterans' ability to function independently. This Rehabilitation Research and Development (RR&D) Merit Award proposal builds on the applicant's prior experience in rotator cuff tear research, including his experience with tissue biopsy, small animal surgery, and imaging techniques. In this proposed project, the applicant will form a core team to develop a translational research program focused on understanding platelet-derived growth factor receptor (PDGFR) inhibition of muscle fatty infiltration after chronic rotator cuff tears and its resulting effect on muscle function. This strategy will entail the application of both tear and repair rabbit models of rotator cuff injury. A core component of this project is to prevent fatty infiltration (FI) by inhibiting PDGFRa-MSCs (platelet-derived growth factor receptor-mesenchymal cells) and treating atrophy with direct electric muscle stimulation (ES).